Research Training on Alcohol Etiology and Treatment

This renewal application requests 5 years of support for our Training Program on Alcohol Etiology and
Treatment. This interdisciplinary training program was established in 2000 and designed to provide six
postdoctoral trainees with both general and individualized research training on the etiology and treatment of
alcohol problems. This renewal reduces the postdoctoral training program to four postdoctoral fellows to allow
for the expansion of the program to now include four predoctoral trainees. The predoctoral trainees will be
from four departments with strong alcohol research, psychology, community health and health behavior, social
work, and pharmacology/toxicology. In addition to these disciplines, faculty also include representation of such
diverse yet complementary fields such as sociology, epidemiology, psychiatry, nursing, and the
psychobiological sciences (clinical neuroscience, applied biopsychology, behavioral neuroscience). Research
training is conducted within the mentor's research program, as specified within Individual Training Programs
(ITP) approved and monitored by the Steering Committee. With this diverse faculty, we are able to provide
trainees with a broad, yet deep, foundation of knowledge regarding the biological, psychological, and social
aspects of alcohol use and alcohol use disorders. The core curriculum includes: 1) a one credit (CHB 620—
Special Topics) course each semester. The course includes seminars (e.g., Foundations of Interdisciplinary
Alcohol Research, Seminal Articles in Alcohol studies), grant writing workshops, statistics workshops,
professional development, and Training in the Responsible Conduct of Research. All of these seminars and
workshops will rotate throughout the training to ensure that each trainee will have a chance to participate in all
of the programming; 2) CRIA's seminar series and 3) formal didactic coursework identified in the ITP as
important for research career progress. In addition to the core curriculum, there are a number of supplemental
training opportunities, particularly through the Clinical and Translational Science Institute. In the past 15 years,
22 of the 29 (76%) trainees who have completed the program have continued research careers in academic
positions with colleges/universities or have accepted assistant professor positions. Of the 20 with established
academic positions, 15 (75%) have served as a PI or Co-I on an NIH research grant. During the period of their
training, trainees who completed training in the past 10 years published an average of eight peer reviewed
articles. All activities of the training grant are assessed and trainees who have completed training are
contacted every two years to provide their

Public health relevance
Excessive alcohol use and alcohol use disorders have an enormous impact on public health, with annual costs in the U.S. estimated to be $249 billion, and the social costs ranging from family disruption to criminal justice are also immense. Alcohol use disorders reflect the interplay of neurobiology, genetics, psychology, and socio-cultural factors. This underscores the critical need for inter-disciplinary research to understand, develop, and test science-based approaches and the necessity of inter-disciplinary training for alcohol researchers in order to develop appropriate interdisciplinary approaches to reducing the harms from alcohol.